Automated interactive definition of the clinical target volume in radiation oncology

Abstract
Identifying the appropriate clinical target volume (CTV) to capture microscopic disease is the greatest limitation
in clinical radiotherapy in efforts to offer maximally conformal treatment to minimize radiation associated
toxicity. The challenge of defining the CTV comes from inherent uncertainty in the tumor spread beyond the
visible gross tumor volume (GTV). Delineation of the CTV is a laborious manual process. Furthermore, there
exists a practical disconnect between CTV contouring and the subsequent treatment plan dose optimization.
Exploration of the real tradeoff between covering malignancy with the dose effective for tumor control and
delivering potentially toxic dose to surrounding healthy tissues is currently impossible. The broad long-term
goal of this project is to make CTV definition easier and better. We will focus on two challenging disease sites,
glioma and sarcoma. Our methods can be generalized to essentially all other disease sites. The first aim is to
automate CTV definition. This will be accomplished by machine learning of barrier structures and anatomic
domains that are known to affect the spread of tumor beyond the visible GTV. The CTV will be expanded in 3D
taking the preferred direction of spread in the different anatomic domains (such as spread along muscle fibers)
into account. The second aim is to develop a user interface that lets the user interact with the automatic CTV
definition system, to avoid a black box impression. The user can edit the auto generated contour if necessary.
Any changes will be logged and used to retrain the system. The CTV expansion will be integrated in a multi-
criteria optimization system for treatment planning, where the user can interactively explore the dosimetric
impact of CTV expansion on the dose coverage of the tumor and dose burden in normal structures. In the third
aim we will test the hypotheses that this system will lead to a more consistent definition of the CTV, better time
efficiency, and better treatment plans leading to provable improvements of the expected clinical outcome. We
will make the system available as a standalone system to academic users and hospitals.

Public health relevance
Narrative The definition of the clinical target volume in which high doses of radiation are delivered to treat cancer is the weakest link in the radiation therapy chain. It is currently a cumbersome manual process in which a radiation oncologist draws the target contours manually, with many uncertainties involved, leading to a large variability between contours drawn by different physicians. In collaboration with a leading company in radiation treatment planning, we develop a machine learning based approach to define the clinical target volume semi- automatically, which will lead to greater efficiency in defining the clinal target, more consistency, and better treatment plans for the patients.